G-RISE at the University of Puerto Rico Medical Sciences Campus

The G-RISE at the University of Puerto Rico Medical Sciences Campus (UPR-MSC) program will support
the biomedical Ph.D. programs of the UPR School of Medicine Division of Biomedical Sciences (DBS) and
the School of Pharmacy. The goals of the G-RISE at the UPR MSC program are to provide support to pre-
doctoral students from underrepresented groups in mentored biomedical and behavioral research, enrich
the research environment at the UPR-MSC and enhance the academic offerings of the Ph.D. Programs of
the Schools of Medicine and Pharmacy. These goals will be pursued using the following objectives: to
develop trainees’ technical and professional skills required to conduct research in a responsible and
rigorous manner; to provide training to G-RISE faculty that will help them become more reflective mentors
and develop better mentoring strategies; to provide broad didactic opportunities through a dynamic
seminar series across biomedical fields that will allow trainees and faculty to acquire state-of-the-art,
forefront knowledge needed to advance their chosen field; to provide a strong foundation and operational
skills on scientific reasoning, rigorous research design, experimental methods, quantitative and
computational approaches, and data analysis and interpretation; to ensure trainees retention, degree
completion and transition to research careers. Innovative activities are included, such as a course in Data
Rigor and Reproducibility for Biomedical Translational Scientists, fellowship proposal and teaching skills
courses. In addition to the activities designed to address the specific objectives we have established to
achieve the above stated goals, participating Ph.D. students will attend seminars and/or workshops or
courses developed in the DBS that provide instruction in Responsible Conduct in Research during their
predoctoral training at the University of Puerto Rico Medical Sciences Campus. The RISE Program will
ensure that any material developed under the auspices of its research education program be disseminated
broadly, on campus or on the internet.

Public health relevance
The over-arching goal of the G-RISE RISE Program at the University of Puerto Rico Medical Sciences is to support educational activities that enhance the diversity of the biomedical, behavioral and clinical research workforce, through support of creative educational activities with a primary focus on: Research Experiences and Courses for Skills Development. The University of Puerto Rico Medical Sciences Campus requests support for Mentored Research Experiences and Skills Development activities for better prepare URM scientists. Innovative approaches are included, such as a course in Reproducible Quantitative Research for Biomedical Translational Scientists, fellowship proposal writing and teaching skills courses.